HUMAN BIOSPECIMAN REPOSITORY - HISTORICAL COLLECTIONS

This is a project to continue all necessary services, qualified personnel, material and facilities not otherwise provided by the government for storing, monitoring and distributing, to authorized investigators, samples of blood, urine, tissue, and other materials collected by the following NICHD research projects/programs: Collaborative Perinatal Project (CPP); NICHD Intramural Specimens; Vaginal Infections and Prematurity; Calcium for Preeclampsia Prevention; Maternal Fetal Medicine Units Network; Women's Health Study/Women's Interagency HIV Study; Longitudinal Study of Vaginal Flora; Group B Strep (GBS) Specimen Collection; Reaching for Excellence in Adolescent [HIV] Care and Health (REACH); NICHD International Site Development Initiative (NISDI); Efficacy Trial of Spermicidal Agents (ETSA); Combined Antioxidant and Preeclampsia Prediction Study; Prevention of Mother to Child [HIV] Transmission Study (PMTCT); Pediatric AIDS Clinical Trials Group (PACTG/ACTA); Pediatric European Network for Treatment of AIDS 11/Treatment Interruption in Children with Chronic HIV Infection (PENTA 11/TICCH); Neonatal Research Network; Brain and Tissue Bank; Genetic of Preeclampsia; Stillbirth Collaborative Research Network (SCRN); Prenatal Alcohol in SIDS and Stillbirth (PASS); Pediatric HIV-AIDS Cohort Study (PHACS); Biocycle; and Endometriosis Study (ENDO).